PHARMACOKINETICS OF FK506 IN PATIENTS WITH MILD AND SEVERE HEPATIC DYSFUNCTION

This protocol will characterize the oral and intravenous PK of FKk506 in patients with hepatic dysfunction who are awaiting trnsplant.